Improving mutant KV11.1 trafficking to treat Long QT Syndrome

PROJECT SUMMARY
Long QT Syndrome (LQTS) occurs due to slowed cardiac repolarization, which is reflected as long QT
intervals on patient electrocardiograms. This prolongation increase the risk of fatal cardiac arrhythmias. The
voltage-gated potassium ion channel, KV11.1, comprises 25-40% of LQTS cases. Around 90% of loss-of-
function KV11.1 variants cause reduced intracellular transport (trafficking) of KV11.1 protein, reducing its cell
surface expression and causing LQTS. Currently, there are no clinically approved drugs that treat this
mechanism. My high-throughput drug screens identified evacetrapib as a drug candidate that improves KV11.1
trafficking and activates the channels. For this project, I aim to 1) test evacetrapib for drug repurposing in
trafficking-deficient KV11.1 variants and 2) identify targetable KV11.1 protein interactions that could improve
trafficking and function.
Aim 1 uses high throughput variant screening and human induced pluripotent stem cell cardiomyocytes
(hiPSC-CMs) to assess KV11.1 variant trafficking and function. In collaboration with Brett Kroncke, this
proposal uses published multiplexed assays of variant effect (MAVE) to generate more than 23,000 KV11.1
variants and identify variant-specific trafficking response to evacetrapib. Evacetrapib failed phase III clinical
trials for high cholesterol, but patients tolerated the drug well, suggesting it could be repurposed to treat Long
QT Syndrome. Thus, data from the MAVE will inform testing in translational hiPSC-CM models. Gene-edited or
patient-derived HiPSC-CMs with responsive KV11.1 variants will be used to further confirm evacetrapib’s
efficacy and facilitate the translation of the findings into clinical practice.
Aim 2 explores KV11.1-protein interaction networks using established affinity-purification coupled with mass
spectrometry protocols and high-throughput siRNA screening. This will identify KV11.1 interacting proteins and
mechanisms that regulate KV11.1 trafficking. Dr. Egly will receive hands-on training in proteomics
(instrumentation and analysis), which complements prior learning from courses and workshops.
Dr. Christian Egly’s career goal is to establish an independent research lab focused on ion channel trafficking
and finding new treatments for cardiac arrhythmias. The training plan highlights key areas for Dr. Egly’s growth
including research independence in hiPSC-CMs (Aim 1) and proteomics (Aim 2), professional development,
faculty development, and courses/learning of statistical analysis and bioinformatics. Mentors, Björn Knollmann,
MD, Ph.D., and Lars Plate, Ph.D., have excellent track records in training students, fellows and early career
investigators. Advisor Dan Roden, MD, offers decades of experience in cardiac electrophysiology and
arrhythmia research and has trained multiple K awardees. Dr. Yaomin Xu provides biostatistical support to the
project. Lastly, Vanderbilt University is an excellent environment with top-notch research facilities and
investigators that will support Dr. Egly’s development towards independence.

Public health relevance
Project Narrative Loss-of-function variants in the voltage-gated potassium ion channel (KV11.1) are associated with Long QT Syndrome, a risk for deadly cardiac arrhythmias, and around 90% of these variants disrupt intracellular protein transport (trafficking) to the cell surface. I will test evacetrapib’s efficacy to improve KV11.1 variant trafficking using human induced pluripotent stem cells and employ proteomics to identify KV11.1 protein interaction networks. This research aims to uncover therapeutic strategies for managing Long QT Syndrome.